Tracing the Health Consequences of Family Support during the COVID-19 Pandemic

PROJECT SUMMARY
The initial health impacts of the COVID-19 pandemic have been unequal across social groups, and disparities
in the economic impact of COVID-19 have amplified existing economic inequalities and health gaps. When faced
with health and economic challenges, Americans often rely on family members, including those who are not
coresident, to provide time help, financial assistance, and shared housing. Yet, for many disadvantaged
Americans, the increased need for help from family comes at a time when the ability of family to provide help is
diminished. Public transfers designed to alleviate economic hardships of the pandemic may interact with family
transfers, but the combined effects are unknown. Despite the interdependence of health and economic
challenges across generations and the effect of family support on health outcomes in the face of challenges,
most research on pandemic effects focuses on individuals and households. This project fills this gap in the
research creating a multidimensional contextual database linked to the Health and Retirement Study (HRS) and
the Panel Study of Income Dynamics (PSID) to examine the effects of the pandemic across generations of
American families. The HRS and PSID have collected data on the health and well-being of individuals and their
family members for decades, include supplements on COVID-19 health and economic challenges and on public
and private transfers to combat these challenges, and will continue indefinitely to support an understanding of
the health impacts during and in the years following the pandemic. This project enhances these data by building
a contextual database on the pandemic linkable to the generations of families in the HRS and PSID across
dimensions of exposure to risk; state, local, and school policies; local economic conditions; health care
availability; preexisting health factors; and structural inequalities. The proposed project addresses four Aims: (1)
build and maintain a multidimensional contextual database linked to generations of HRS and PSID families; (2)
describe how pandemic-related health and economic challenges differed across groups and were shared within
families; (3) assess how care, financial support, and coresidence from family members responded to pandemic-
related health and economic challenges and how each interacted with public transfer programs; and (4) study
the physical and mental health effects in the immediate aftermath and the years following the pandemic and
whether family support and public transfers mitigated negative health effects. Disparities across race-ethnicity,
socioeconomic status, gender, age and retirement status, and family structure are assessed in each aim. Causal
effects of the impact of the pandemic will be estimated using a combination of subjective assessments elicited
from respondents and analytic strategies. The results provide a comprehensive understanding of the health and
economic challenges the pandemic posed to American families and how it impacted their physical and mental
health. Consortium collaborations will facilitate harmonization of contextual factors and health outcomes and
support dissemination of the contextual data resource to the broader research community.

Public health relevance
PROJECT NARRATIVE This project examines experiences of health and economic challenges during the COVID-19 pandemic across generations of American families and how families responded to these challenges. The project creates a contextual database with information on multiple domains linked to two nationally-representative surveys of extended families to describe the degree to which family members shared the same challenges during the pandemic and how this affected their ability to help each other with time, money, and shared housing. The project focuses on the pandemic’s immediate and intermediate effects on health, whether it exacerbated health disparities, and if family support mitigated negative health effects.